A Scalable Platform to Discover Antimicrobials of Ribosomal Origin

PROJECT SUMMARY/ABSTRACT
Natural products have been by far the most prolific source of chemical matter that has been developed into
modern antibacterial and antifungal drugs by the pharmaceutical industry. However, despite the pressing need
for new drugs to address the alarming rise of drug resistance, especially amongst Gram-negative bacterial
pathogens, the rate of discovering natural products has diminished. In this R01 project, we propose to develop
a scalable platform to produce novel ribosomal natural products, i.e. ribosomally synthesized and
posttranslationally modified peptides (RiPPs). With more than two dozen distinct classes of RiPPs identified thus
far, and several new classes being identified each year, RiPPs represent a promising addition to the antibacterial
and antifungal drugs biosynthesized by polyketide and non-ribosomal pathways yet they remain vastly
underexploited by comparison. Specifically, we will integrate bioinformatics, synthetic biology, and analytical
chemistry tools to develop a Fully Automated, Scalable, and high-Throughput (FAST) pipeline for the discovery
and characterization of one thousand novel RiPPs from uncharacterized RiPP biosynthetic gene clusters (BGCs)
of both known and unknown classes. The resultant novel RiPPs will be assayed for their antibacterial and
antifungal activities as well as other related biological activities towards neglected and tropical diseases
(tuberculosis and malaria) through a collaboration with Lilly's Open Innovation Drug Discovery Program
(openinnovation.lilly.com). This project represents the first large-scale attempt at unlocking the potential of RiPPs
as a source of new antibacterial and antifungal drugs, which based on their genetic compactness, are ideally
suited for the synthetic biology methods and goals described within. For this project, we propose three
interrelated but independently achievable specific aims. Aim 1 will discover novel RiPPs from known classes
using lower throughput methods. Aim 2 will scale up the discovery of novel RiPPs from known classes using the
FAST pipeline. Aim 3 will predict and produce RiPPs from classes that have not yet been reported, which will
ensure a variety of novel natural product scaffolds. Success in the overall project will change the paradigm for
natural product discovery and will potentially have a profound impact on the pharmaceutical industry.

Public health relevance
PROJECT NARRATIVE The majority of existing drugs are natural products or derivatives thereof. However, the rate of discovering new natural products has diminished despite an increased need for new drugs especially with respect to antibiotics. The goal of our proposed studies is to discover and characterize more than one thousand novel ribosomal natural products and assess their utility as new antibiotic compounds.